Developing a Mouse Model of Campylobacter jejuni

The overarching objective of this effort is to establish a reproducible mouse model of disease caused by Campylobacter jejuni that will be applicable to testing interventions.